Advancing CNS drug delivery via epigenetic modulation

Abstract
Lysosomal storage disorders (LSDs) are a group of inherited diseases characterized by dysfunctions in
lysosomes, with cumulative frequency of 1 in 7000 live births. Over 2/3 of LSD patients present an involvement
of the central nerve system (CNS) with a broad spectrum of severity (nLSD), which makes LSDs the most
common cause of pediatric neuronopathic diseases. Allogeneic hematopoietic stem cell transplantation (HSCT)
or enzyme replacement therapy (ERT) are main treatment options for LSDs. However, they are largely
unsuccessful in reversing neurological complications due to the poor penetration of the enzymes into the CNS,
a major obstacle in treating nLSD. The impact of the proposed study is driven by the unmet medical need for
efficient treatment of inherited nLSDs AND the major limitation of enzyme-delivery into the CNS.
The cation-independent mannose-6-phosphate receptor (M6PR) plays a critical role in lysosomal enzyme
trafficking and intercellular transfer for the majority of lysosomal enzymes, which is essential for metabolic cross-
correction in treating LSDs. Developmental decline of M6PR on blood-brain-barrier (BBB) during early postnatal
period in mouse and human is attributable to the lack of CNS enzyme delivery into adult brain. Using a dual
luciferase reporter system with site-mutagenesis, we have recently identified microRNA-143 (miR143) as an
epigenetic modulator to reduce M6PR protein levels on brain microvessels (BrMV). Using a mouse model of
Hurler syndrome (severe mucopolysaccharidosis type I, MPS I), which is caused by the deficiency of α-L-
iduronidase (IDUA), we demonstrated functional rescue of M6PR-mediated IDUA transfer in the brain of double-
knockout (MPS/miR-143KO) mice with long-term CNS therapeutic benefits, as well as in human vascular
endothelial cells by sequestration of miR-143 with miR-143-sponge sequences. The data provide strong
scientific premise for the development of a novel approach that would selectively “open” BBB to systemic
enzymes provided by any current treatment options or future enzyme/gene/cell therapies for synergistic CNS
benefits in many nLSDs. In this proposal, we aim to develop an adeno-associated viral vector (AAV)-based
translatable platform to “restore” M6PR pathway on mature BBB for advanced delivery of therapeutic enzymes
into the CNS with 3 aims, including developing optimal artificial miR143 inhibitor (143in) and expression
cassette(s) for robust and targeted reduction of miR143 on brain endothelia cells (Aim 1), in vivo examination of
“on-target” and “off-target” expression and effects in mice with AAV/143in delivery (Aim 2), as well as preclinical
evaluation of BrMV-targeted AAV/143in in correcting CNS abnormalities in MPS I mice by enzyme therapy
derived from genetically modified erythroid/megakaryocytic lineages (Aim 3). The studies will provide a proof-
of concept for a new in vivo miRNA-inhibitor mediated, brain-targeted approach that could be applicable for
many other nLSDs involving M6PR pathway AND neurological diseases benefiting from advanced CNS delivery
of therapeutics via adapting M6PR-mediated transport pathway by modification with M6P residues or IGF2-tag.

Public health relevance
Narrative: It has been a major unmet medical need for the development of efficient brain delivery across the blood-brain barrier with wide distribution of the therapeutic macromolecules to many types of brain cells in treating a wide variety of neurological diseases. The goal of this project is to develop a novel platform with advanced brain delivery of therapeutic proteins by coalescing in vivo epigenetic alteration of microRNA with targeted gene transfer and restricted transgene expression for improved CNS treatment of Hurler syndrome, a neurologic lysosomal storage disease (nLSD). Such therapeutic approach would have significant and broad application across many other nLSDs or neurological diseases.